Alternative Stimulation Mode and Location for Auditory Hallucination Neuromodulation Treatment

Project summary: Current efforts to use rTMS to treat auditory hallucinations refractory to available
antipsychotic medications show promising efficacy but replicability of the effect in well-controlled clinical trials
remain unsatisfactory. The proposed study is to use a novel approach to design rTMS treatment for auditory
hallucination that is based on a strong neural circuitry mechanism on auditory hallucination formation. The
project will recruit patients with schizophrenia spectrum disorders and randomize patients into active rTMS
versus sham rTMS groups followed by four fMRI based target engagement outcome assessments at baseline
and after 10, and 20 visits of daily rTMS plus a 2 week maintenance phase. The proposal will use new
stimulation site and stimulation mode combinations that are different from previous rTMS trials on auditory
hallucination, but are conceptualized to be more closely linked to neural circuitry mechanisms of auditory
halluciantion formation. The proposal will include two phases as two separate projects. The first proposed
project is a R61 for two years. If the Go/Nogo milestones are not met, the study will end. If all Go/Nogo
milestones are met, it will proceed to a R33 project for three more years. The trial will test the proposed
mechanism of action at brain circuitry level and determine whether the new stimulation site and mode strategy
will indeed significantly engage the proposed circuitry of action through modulating its functional connectivity in
the direction for improving auditory hallucination.

Public health relevance
Project Narrative The project proposes to use transcranial magnetic stimulation to modulate the brain circuitry linked to auditory hallucinations using a novel stimulation site selection and stimulation mode combination, and to determine whether it would correct the circuitry abnormality.